HEALing Communities Study Health Equity Research

Project Summary/Abstract
The opioid overdose crisis persists in the United States, exacting a heavy burden of morbidity and mortality.
There is a robust evidence base for reducing opioid overdose, including overdose education and naloxone
distribution (OEND), medication for opioid use disorder (MOUD), and safer opioid prescribing and disposal.
However, community-level adoption of these evidence-based practices (EBPs) in healthcare, behavioral
health, and criminal legal systems is suboptimal.
The HEALing Communities Study (HCS) designed the Communities That HEAL (CTH) intervention to help
increase adoption of EBPs and ultimately reduce opioid overdose deaths in 67 communities across four U.S.
states: Kentucky, Massachusetts, New York, and Ohio. The CTH is a coalition-led and data-driven intervention
that includes three components: (1) community engagement; (2) the Opioid-overdose Reduction Continuum of
Care Approach (ORCCA), which is a menu of EBPs; and (3) a set of communication campaigns to reduce
stigma and drive demand for EBPs.
Over the course of the HCS, the United States faced stark racial, ethnic, and socioeconomic differences in
COVID-19 outcomes alongside the horrific eight-minute video of George Floyd’s killing in police custody.
These events called attention to pervasive inequities in our nation’s systems. In response, HCS researchers
refined the CTH intervention for wait-listed communities to include a more explicit focus on health equity.
As the Data Coordination Center (DCC), RTI will work with research sites to explore implementation
outcomes for equity-related enhancements to the CTH intervention. Under this supplement, we will conduct
new analyses to assess coalition members’ level of satisfaction with the diversity of membership (Aim 1);
coalition members’ perceived need for training, resources, and tailored strategies for racial and ethnic
minoritized and other underserved groups (Aim 2); the frequency and focus of coalitions’ discussions about
racial equity (Aim 3); the extent to which the reach of implemented OEND and MOUD strategies reflect the
sociodemographic characteristics of Wave 2 communities (Aim 4); and associations among community-level
measures of stigma and social determinants of health, the adoption of OEND and MOUD strategies intended
to reach special populations, and EBP reach in Wave 2 communities (Aim 5).
The DCC is equipped to collaborate with HCS research sites to achieve these aims. Multiple Principal
Investigators, Drs. Emmanuel Oga, LaShawn Glasgow, and Gary Zarkin, are experienced leaders of multisite
studies with expertise in substance abuse, community engagement, implementation science, and health
equity. The broader team includes analysts and a coordinator who have supported the development of de novo
data sources for proposed analyses, and analysts have relevant experience conducting other implementation-
oriented analyses under the parent HCS. Achievement of the new equity-focused aims and dissemination of
findings will help build practice-based evidence for community-engaged approaches to equitably addressing
the opioid overdose crisis.

Public health relevance
Project Narrative The HEALing Communities Study tests the Communities that HEAL (CTH) intervention, a coalition-led and data-driven model for increasing adoption of evidence-based practices to reduce opioid overdose deaths in 67 communities across four states. HCS researchers refined the CTH intervention for wait-listed communities to include a more explicit focus on health equity. This supplement aims to explore the implementation outcomes of these equity-focused enhancements, including reach of implemented EBPs to racial and ethnic minoritized and other underserved groups. Findings from this work will help build practice-based evidence for community- engaged approaches to equitably addressing the opioid overdose crisis.